A Confocal Fluorescence Microscopy Brain Data Archive

PROJECT SUMMARY
Brain image data collected by the neuroscience community will continue to grow
dramatically in the next 5-10 years as the push to image physically larger volumes, such as
whole brains from humans and other primates, becomes a focus. The scientific community, with
the support of NIH data sharing policies, expect this valuable data to be shared and made
available to the community as rapidly as possible.
The Brain Image Library (BIL) is a public resource serving the neuroscience community by
providing a persistent scalable repository for sharing microscopy data generated by brain
researchers. Importantly, raw data can be archived with BIL, and all post-processing and
analysis can be completed at BIL and rapidly made publicly available. BIL maximizes data
reusability by providing rapid access to a range of community-specific software suites and user-
specific software which can quickly access a variety of high-performance computational
resources including GPU, CPU, high-RAM and machine learning nodes. This one-stop access
encourages the reuse of data by making it easily accessible to a variety of scientists and
promotes transparency and scientific discovery as the outcomes of any meta-analysis can be
made public and tied directly to the original data content.

Public health relevance
Brain image data collected by the neuroscience community will continue to grow dramatically over the next 5-10 years. Increases in data volume will come from a push to image physically larger volumes such as whole brains from humans (and other primates) and from higher speed for smaller specimens. The Brain Image Library (BIL) is an important public resource for sharing this data by providing a persistent and scalable repository for microscopy data generated by brain researchers.